NONPARAMETRIC ESTIMATION OF CANCER DOSE RESPONSE CURVES

This project involves the development of new methods for estimating dose-response relationships between environmental carcinogens and cancer morbidity, and the application of these methods to new and existing datasets. The high resolving power of the new nonparametric procedures will be utilized to better visualize the characteristcs of environmental exposure and cancer morbidity data. For purposes of validation, results obtained through use of these new procedures will be compared to previously completed analyses of existing data sets. New data from several morbidity studies will also be analyzed in order to further fieldtest, and ascertain the properties of, the new techniques.